Cognitive Complaints and Decline and B-Amyloid Deposition in Non-Demented Elderly

DESCRIPTION (provided by applicant): Subjective declines in memory and thinking abilities are commonly reported in older adults. Recent studies indicate that complaints predict subsequent cognitive decline and incident Alzheimer's disease (AD), at least in some older adults. Furthermore, complaints have been associated with biological markers of AD, such as brain atrophy, reduced brain metabolism, and AD neuropathology on autopsy. These findings suggest that, for some, cognitive complaints likely represent a pre-symptomatic stage of AD which may provide an even earlier therapeutic opportunity than mild cognitive impairment (MCI). Amyloid-beta (Aβ) imaging studies indicate that brain Aβ plaques are present in 20-30% of cognitively normal older individuals, consistent with postmortem studies. Recent reports show Aβ deposition in normal older adults to be associated with longitudinal cognitive decline, brain volume loss, and altered glucose metabolism, supporting the idea of sub-clinical neuronal dysfunction. The proposed research will investigate whether cognitive complaints may represent a facet of early Aβ -associated, sub-clinical neuronal dysfunction, along with subtle cognitive deficits and gradual cognitive decline. It will also investigate the role of personality, mood and reporting bias in the measurement of subjective cognitive complaints and their relationship to Aβ deposition. This career development proposal will provide the foundation for a research program dedicated to investigating the early natural history of cognition associated with AD pathology in aging. To date, my training has afforded me a broad background in clinical neuropsychology and functional MRI. My short-term goals are to undertake in-depth training in Aβ imaging with PET, using Pittsburgh Compound B (PiB); to learn modern psychometric approaches to develop and refine cognitive outcome scales; and to learn advanced approaches to analyzing longitudinal cognitive data. The institutional environment is well-matched to these training goals, including Mentors Dr. William Klunk, a co-inventor of the amyloid tracer PiB, and Drs. Mary Ganguli and Judith Saxton, each a leader in AD and MCI research. Key elements of the career development plan include supervised research experiences with Mentors/Consultants, courses and workshops. The research plan includes implementation of a complete, original PiB-PET study of cognitively normal participants self-referred to a Memory Disorders Clinic, as well as the step-wise development, refinement and validation of a new scale for subjective cognitive complaints. Through these training and research activities, I will establish myself as an independent scientist with a unique set of skills, utilizing neuroimaging and advances in psychometric measurement to investigate early cognitive predictors of AD. This work will contribute significantly toward understanding the prognostic significance of cognitive complaints and amyloid deposition in non-demented individuals. Potentially, it will advance understanding of the extended preclinical phase of AD and how best to initially identify it.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research proposal will determine whether subjective complaints of impaired memory and thinking in older adults are related to the pathological brain changes of Alzheimer's disease (AD). It will investigate the role of personality, mood and reporting bias in the measurement of subjective complaints and their relationship to amyloid-beta plaques in the brain. The results could lead to the development of a new scale to initially screen for the presence of very early AD brain changes, potentially leading to improved future treatment outcomes. Project Narrative This research proposal will determine whether subjective complaints of impaired memory and thinking in older adults are related to the pathological brain changes of Alzheimer's disease (AD). It will investigate the role of personality, mood and reporting bias in the measurement of subjective complaints and their relationship to amyloid-beta plaques in the brain. The results could lead to the development of a new scale to initially screen for the presence of very early AD brain changes, potentially leading to improved future treatment outcomes. __SpecificAimsTextDelimiter__ 10. Specific Aims The goal of this proposed research is to understand the underlying neurobiology of mild subjective and objective cognitive deficits, with a specific focus on Aβ deposition. Specifically, it will examine whether subjective cognitive complaints (SCCs) predict concurrent presence of Aβ on imaging, whether they are associated with longitudinal cognitive decline, and whether personality or mood may modify these associations. Results of this research which applies modern psychometric modeling (Aim 1), item refinement and validation with PiB imaging (Aim 2), and cross-validation in a newly recruited clinical sample (Aim 3), will lead to the development of a novel SCC questionnaire battery. This work will contribute significantly toward understanding the clinical prognostic significance of SCCs and Aβ in healthy individuals, and, potentially, of the nature of the extended preclinical phase of AD and how best to identify it. Specific Aim 1: To use Item Response Theory to refine measurement of subjective cognitive complaints (SCCs) in older adults and investigate associations with dementia indicators. This is a secondary analysis aim using collected data from a five-year, prospective longitudinal population study of MCI (R01 AG023651; Ganguli PI). Hypotheses: a. Compared to traditional memory questionnaire scoring, an IRT-derived measure of subjective cognitive complaints will be more highly associated with dementia indicators, including declining cognitive test scores over time, APOE*4 allele, and MRI hippocampal volume. b. Measurement properties of SCC items will differ for younger-old compared to older-old; item calibration and score refinement will therefore be applied within age groups for optimal assessment by age. Specific Aim 2: To investigate the relationships among SCCs, Aβ deposition, and longitudinal cognitive decline in normal and mildly cognitively impaired older adults. This aim involves adding assessments of SCCs, personality and mood to two on-going parent PiB imaging studies with longitudinal components: PiB Program Project Grant (PPG; POI AG0025204; Klunk PI ) and Klunk MERIT Normal Aging Study(R37 AG025516). Hypotheses: a. Participants with higher measured SCCs are more likely to have PiB(+) scans than those with low SCCs. b. Normal participants with SCCs and PiB(+) scans will have shown decline on neuropsychological test scores over time, retrospective to the time of neuroimaging. c. Personality factors, more so than depression, will modify the association between Aβ deposition and SCCs, such that individuals with SCCs who are low on "Emotional Instability" and high on "Conscientiousness" are more likely to have PiB(+) scans. d. IRT-derived scoring of SCCs (from Specific Aim 1) will yield stronger associations with Aβ deposition than traditional memory questionnaire scoring. Other SCC questionnaire items will vary in their degree of association with Aβ deposition; items will be selected with higher associations to form the basis of a further refined SCC battery. Specific Aim 3: To prospectively determine whether "isolated" SCCs in individuals self-referred to a Memory Disorders Clinic are associated with greater risk for Aβ deposition. This is a primary data collection pilot study in an AD Research Center setting. Hypotheses: a. Individuals presenting at a Memory Disorders Clinic with SCCs and normal neuropsychological test performance are more likely to have PiB(+) scans, compared to healthy controls without SCCs. b. The refined SCC questionnaire battery (from Specific Aim 2) will predict the presence of Aβ deposition. c. As a group, individuals with SCCs and normal neuropsychological test performance will have lower mean scores on sensitive experimental-cognitive tests compared to healthy controls without SCCs.